Assessing Family Management of Childhood Chronic Illness

DESCRIPTION (provided by applicant): Recent estimates indicate that approximately 15 percent of all children between birth and 18 years of age have one or more chronic health impairments. A unique array of strengths and limitations shapes each family's illness management efforts and necessitates individualized nursing interventions if optimal individual and family functioning is to be supported. To understand family life in the in the context of childhood chronic illness it is necessary to understand how the illness and treatment regimen are incorporated into family life. However, despite the existence of well-established instruments to measure general family processes and functioning, no measures exist that assess family illness management and incorporation of the illness into family life. The purpose of this study is to develop and evaluate such an instrument. Specific aims are: (1) complete development of items for the Family Management Style Survey (FMSS), (2) evaluate the content validity of the FMSS through input from expert family nurse researchers, clinicians and parents of children with chronic illness, and (3) determine the psychometric properties of the FMSS through a field test to assess its underlying factor structure, reliability, typological groupings, and construct validity. Considerable work on the conceptual underpinnings of the proposed instrument has been completed and served as the basis for generating a pool of 97 items. Efforts to evaluate the content validity of these items are ongoing. The current application seeks funding to complete the development of the instrument. Think aloud interviews with 30-45 parents of children with chronic illness will be completed to further assess the content validity of the FMSS. Field-testing will entail telephone interviews with a sample of 700 parents in order to assess the instrument's psychometric properties. The sample will be recruited to include single and two parent families and a diversity of demographic and illness characteristics. During telephone interviews, parents will complete the FMSS and other measures of child and family functioning. The study combines two innovative approaches to instrument development (think aloud interviews and G-study) with established approaches for assessing reliability and validity. By providing a valid reliable measure of patterns of family response to childhood chronic illness, the FMSS will further our ability to generate knowledge of the family context of illness as well as our ability to develop interventions that address the unique and varying needs of families.